Targeting LRRC8 signaling to prevent & treat arterial thrombosis in type 2 diabetes

Project Summary
Cardiovascular disease (CVD) including stroke and myocardial infarction (MI), and Type 2 diabetes (T2D) are
overlapping global pandemics. CVD is the most common cause of death in patients with T2D and the economic
burden of stroke and myocardial ischemia in patients with T2D is staggering. While newer glycemic control
agents like SGLT2 inhibitors and GLP1 agonists can help reduce CVD events in T2D, significant residual CVD
risk remains. Stroke and MI most often occur when a platelet-rich thrombus form at the site of a ruptured
atherosclerotic plaque, occluding the vessel lumen, and resulting in downstream ischemia. There are at least
four classes of drugs available to inhibit platelet rich thrombi formation including aspirin, P2Y12 receptor inhibitors,
and thrombin receptor inhibitors. While current antiplatelet drugs can reduce CVD events and death, their
therapeutic potential is limited by major bleeding. Thus, there is a large unmet clinical and commercial need
for a drug that improves glycemic control in T2D and also safely prevents cerebral and coronary vascular
thrombosis. Senseion Therapeutics Inc. has been developing novel glycemic control agents derived from a tool
compound SN-401 (SN-4XX) targeting LRRC8 proteins. In the course of developing these T2D therapeutics,
we discovered human genetic evidence implicating LRRC8 regulation of platelet function in humans. We
then validated LRRC8 proteins as a target for antiplatelet activity using targeted mouse genetics, and confirmed
both in vitro and in vivo antiplatelet/antithrombotic activity of a novel SN-401 derived compound that also
demonstrates glycemic control activity. We propose that SN-4XX compounds represent a first-in-class
therapeutic approach with dual glycemic control and antithrombotic activity. We anticipate these drugs
to fill a large unmet clinical need to improve glycemic control in T2D and also safely prevent cerebral
and coronary vascular thrombosis, reducing the large residual risk of CVD events associated with T2D.
Phase 1 AIMS:
· AIM 1: Evaluate previously synthesized compounds for in vitro antiplatelet and in vivo antithrombotic
activity.
· AIM 2: Complete in vitro Absorption, Distribution, Metabolism, Excretion, Toxicity.
Phase 2 AIMS:
· AIM 1: Perform in vivo oral dosing pharmacokinetics, in vitro ion channel selectivity studies, and in vivo
dose range-finding toxicity studies.
· AIM 2: Perform pre-clinical SN-4XX dose-response, head-to-head efficacy, combination therapy and
reversibility for antithrombotic activity versus bleeding.
· AIM 3: Manufacture the lead SN-4XX compound under cGMP conditions required for all IND-enabling
studies, at least Phase I clinical studies, and all 24-month stability studies.

Public health relevance
Project Narrative Type 2 diabetes (T2D) and cardiovascular disease (CVD) are major overlapping health concerns in today’s society. Therefore, developing novel drugs that treat both type 2 diabetes and thrombosis is a therapeutic priority. The proposed research is relevant to the mission of the NCATS because it proposes to develop LRRC8 complex modulators (SN-4XX) for to treat both T2D and thrombotic diseases to reduce stroke myocardial infarction in T2D patients. Exploring this therapeutic approach and testing a series of LRRC8 modulators will expand our understanding of novel therapeutic avenues and delineate an innovative target for the treatment and prevention of diabetes and cardiovascular disease.